Multimodal and Generative AI for Pathology

Abstract
The microscopic examination of stained tissue is a fundamental component of biomedical research and
for the understanding of biological processes of disease which leads to improved diagnosis, prognosis,
and therapeutic response prediction. Ranging from cancer diagnosis to heart rejection and forensics the
subjective interpretation of histopathology sections forms the basis of clinical decision making and
research outcomes. However, it has been shown that such subjective interpretation of pathology slides
suffers from large interobserver and intraobserver variability. Recent advances in computer vision and
deep learning has enabled the objective and automated analysis of images. These methods have been
applied with success to histology images which have demonstrated potential for development of
objective image interpretation paradigms. However, signiﬁcant algorithmic challenges remain to be
addressed before such objective analysis of histology images can be used by clinicians and researchers.
In this R35 renewal leveraging extensive experience in developing and disseminating research software
based on deep learning the PI and his team will pioneer novel algorithmic approaches to address these
challenges including but not limited to: (1) unimodal and multimodal self-supervised model for
computational pathology (2) fundamental redesign of data fusion paradigms for integrating information
from microscopy images and molecular proﬁles (from multi-omics data) for improved diagnostic and
prognostic determinations (3) developing visualization and interpretation software for researchers and
clinical workﬂows to improve clinical and research validation and reproducibility. The system will be
designed in a modular, user-friendly manner and will be open-source, available through GitHub as
universal plug-and-play modules ready to be adapted to various clinical and research applications. We
will also develop a web resource with pretrained models for various organs, disease states and subtypes
these will be accompanied with detailed manuals so researchers can apply deep learning to their
speciﬁc research problems. Overall, the laboratory’s research will yield high impact discoveries from
pathology image analysis, and its software will enable many other NIH funded laboratories to do the
same, across various biomedical disciplines.

Public health relevance
Project Narrative This project involves the development of deep learning-based algorithms for pathology image analysis. The renewal of this grant will enable us to continue the development of open-source methods and software for microscopy image analysis that will enable basic and applied research in biomedicine.